Developmental stuttering: Population-based genetic discovery

ABSTRACT
Stuttering is a developmental speech disorder that has one of the highest familial recurrence rates among
communication disorders with complex inheritance. While worldwide population prevalence of persistent
developmental stuttering is 1%, and 5-6% of children stutter developmentally, an increased prevalence of
stuttering (11-14%) has been reported in children in Australia. Genes associated with risk of the disorder have
yet to be identified in the non-consanguineous general population; few studies have been conducted on the
genetic susceptibility of developmental stuttering, each focusing on families from genetic isolates with high
levels of consanguinity. Large-scale, well-powered, population-based studies have not yet been undertaken to
detect genomic variants associated with stuttering risk, and as a result extremely little is known about the
molecular underpinnings of developmental stuttering. To address this gap in knowledge we propose the follow
specific aims. Aim 1) We will build on our existing research program by collecting an additional 2,000 saliva
samples from participants diagnosed with developmental stuttering who receive treatment from globally
recognized stuttering centers located in England, Australia, Ireland, and the USA. We will also collect through
an innovative social media recruitment campaign bringing our total sample of developmental stuttering cases
to 3,000. All participants will have diagnoses confirmed by specialists trained in speech and language
pathology, dense phenotypic data recorded detailing severity and case history of developmental stuttering, and
will be included in genetic analyses utilizing two primary approaches. Aim 2) First, Multi-Ethnic Genotyping
Arrays (MEGA) will capture over 2 million variants, providing a genome-wide backbone that will be imputed to
the latest whole genome reference panel in all samples, allowing for robust tests of common variant
association genome-wide, and second, Aim 3) whole exome sequencing will be performed to selectively
capture variation within all protein-coding genes, providing an ideal portrait of the genic regions that are
disproportionately burdened with rare and functional variation. A minimum of 5,000 population-based ancestry-
matched controls with no known history of speech and language impairment will be selected from Vanderbilt
University's BioVU DNA databank as well as the Atherosclerosis Risk in Communities (ARIC) Study. Joint
recalling and analysis using these control datasets will power our comprehensive genetic analyses of
recovered and persistent developmental stuttering, generating an extremely rich, public resource of results for
future genetic, functional, and translational studies. Aim 4) We will identify an additional 1,000 developmental
speech disorder cases and 1,000 ancestry-matched controls via electronic medical records in BioVU for
replication of top findings. Together, these complementary approaches will lead to identification and validation
of genes and pathways contributing to risk of developmental stuttering, providing significant insight into a very
common, highly heritable, and often debilitating disorder that today has a largely unknown biological etiology.

Public health relevance
PROJECT NARRATIVE Developmental stuttering affects 5% of children and 1% of adults worldwide, and exhibits a sibling relative risk of 50-70%; however despite this high population prevalence and remarkably high heritability, no large-scale population-based genetic analyses of stuttering have ever been undertaken. The present application proposes to enhance our existing data resources by enrolling and genotyping an additional 2000 patients who stutter and performing whole exome sequencing and analysis on our total cohort of 3000 cases of developmental stuttering with secondary replication in an additional 1000 cases and 1000 controls. This study represents the largest and most comprehensive genetic analysis of stuttering ever performed and the results obtained in this study will be critical to improving basic understanding of the mechanisms that contribute to risk and will provide a launch point for future studies and therapeutic strategies.